Prefrontal cortical microcircuit mechanisms for reciprocal interactions between arousal and ethanol consumption

Project Summary/Abstract
Alcohol use disorder (AUD) exacts a major personal, economical, and societal toll. Given its high lifetime
prevalence, there is an urgent need to understand neurobiological mechanisms underlying AUD pathophysiology
to develop effective therapeutic strategies. Dysfunction of stress-related neuroendocrine and autonomic arousal
pathways are highly associated with alcohol-related behaviors. Repeated alcohol use increases arousal.
Moreover, higher arousal levels in treatment-seeking AUD patients correlates with higher rates of relapse. These
findings suggest reciprocal interactions between arousal and alcohol use, such that higher basal arousal
promotes alcohol drinking, which further exacerbates arousal. A challenge in understanding the neurobiological
mechanisms mediating interactions between arousal and drinking is the lack of preclinical animal models that
allow quantification of drinking together with longitudinal measurements of arousal and neuronal activity. We
addressed this by designing a voluntary ethanol consumption paradigm for head-fixed mice combined with two-
photon calcium imaging for neuronal activity recordings and pupillometry for measuring arousal. Our preliminary
experiments show that the anterior cingulate cortex (ACC) subdivision of the prefrontal cortex potently increases
arousal. Basal levels of arousal and arousal-related ACC activity are correlated with the amount of ethanol
consumption, suggesting that the ACC contributes to arousal modulation of drinking. Cortical activity is critically
shaped by inhibition from local interneurons. The vasoactive intestinal polypeptide (VIP) expressing interneurons
are particularly important as they inhibit other interneurons, leading to disinhibitory excitation of the ACC. We
hypothesize that ACC VIP neurons are a key node for reciprocal interactions between arousal and ethanol
consumption. In Aims 1 and 2, we test the hypothesis that VIP neuron-mediated disinhibition increases arousal
and ethanol consumption. In Aim 3, we will determine if repeated ethanol consumption increases VIP-mediated
disinhibition, leading to hyperarousal that further promotes drinking. We will test these hypotheses using a
combination of advanced approaches including multicolor two-photon calcium imaging, multicolor optogenetics,
machine vision-assisted closed-loop optogenetics, and ex-vivo slice electrophysiology. Together, these
mechanistic studies will determine how VIP neurons both contribute to and are affected by drinking, establishing
them as a key therapeutic target for modulating drinking driven by aberrant arousal.

Public health relevance
Project Narrative Alcohol use disorders (AUD) exact a major personal, economical, and societal toll, highlighting the urgent need for developing effective therapeutics. Reciprocal interactions between autonomic arousal and alcohol consumption play a key role in the etiology of AUD, but the underlying neurobiological mechanisms are poorly understood. By establishing how top-down modulation of arousal by the prefrontal cortex affects drinking and how drinking itself modifies top-down control, this proposal will identify novel neural therapeutic targets for treating excessive drinking driven by aberrant arousal.